Mechanisms of pathogenic microglial populations in CNS inflammation

PROJECT SUMMARY/ABSTRACT
In multiple sclerosis (MS), microglia contribute to oxidative stress and tissue damage leading to the progression
of disease. The molecular mechanisms that regulate the activation of microglia towards oxidative stress
phenotype remain poorly understood, hindering the development of effective treatments. Blood-brain barrier
(BBB) damage is an early and common pathology linked to microglial activation, oxidative stress, and
neurodegeneration in MS. Our prior studies have identified that microglia sense BBB leaks and blood proteins
through the transcriptional activation of oxidative stress, metabolic and interferon signaling pathways in
neurodegenerative disease models. We identified the blood coagulation protein fibrin to be both necessary and
sufficient for the induction of pathogenic microglia. Our preliminary observations profiling the transcriptional and
epigenetic landscape of pro-oxidant microglia in the experimental autoimmune encephalomyelitis (EAE) model
of MS has identified the ACOD1-Itaconate axis a potential molecular switch governing pathogenic microglia at
sites of BBB damage and fibrin deposits. Aconitate decarboxylase 1 (Acod1) catalyzes the production of
itaconate, an anti-inflammatory metabolite. Our data suggests that Acod1 is epigenetically repressed in
chronically activated pro-oxidant microglia and that therapeutic administration of itaconate ameliorates relapsing
EAE severity and oxidative stress. Prior research and our results have led us to hypothesize that Acod1-itaconate
axis controls neuroprotective microglia responses in CNS inflammation. This proposal will test how ACOD1-
itaconate regulates the transcriptional activation of pro-oxidant microglia in EAE (Aim 1), whether fibrin-CD11b
signaling deregulates ACOD1-itaconate axis in human induced pluripotent stem cell derived microglia and in the
EAE model (Aim 2); and whether interferon signaling drives pro-oxidant microglia activation via epigenetic
remodeling in CNS inflammation (Aim 3). In summary, this project studies pro-oxidant microglial populations and
the molecular and cellular mechanisms that control it, with the goal to identify novel immunomodulatory
therapeutic targets for MS.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis is a chronic inflammatory disease with no cure, which causes significant burden to patients and healthcare. The proposed research aims to identify the molecular mechanisms driving pathological innate immune cells in the central nervous system. By understanding these mechanisms, our research goal is to guide the development of new immunomodulatory therapies to protect the brain from inflammation and disease progression in MS.